Use of CRISPR/Cas9 to treat Huntington disease

A variety of neurological diseases are caused by mutations in the disease genes that result in gain-of-toxicity in the brain. Lowering or blocking the expression of mutant genes is considered an effective therapeutic strategy for the treatment of these neurological disorders. In Huntington’s disease, the CAG repeat expansion in exon1 of the huntingtin gene leads to selective neurodegeneration and progressive neurological symptoms, which are incurable with current therapies. We will use a newly developed technology, CRISPR/Cas9, to eliminate the expression of mutant huntingtin in Huntington disease mice. Our preliminary studies have shown the promising effect of CRISPR/Cas9 to alleviate neurotoxicity and neurological symptoms in Huntington’s disease mice. However, the long-term effects of CRISPR/Cas9 and the safety issue of this new technology remain to be investigated. The current application will examine the gene targeting efficiency of modified Cas9 in adult mouse brains in R21 studies. The R33 studies will rigorously examine the long-term effects of removing mutant huntingtin in Huntington’s disease mice and potential side effects caused by CRISPR/Cas9. Given the increasing demand to use CRISPR/Cas9 to remove mutant genes in the brain to treat a variety of neurological disorders, our studies will have broad implications for the future clinical use of CRISPR/Cas9 to ameliorate neurological symptoms in brain diseases.

Public health relevance
We will use CRISPR/Cas9 to remove the disease gene in Huntington’s disease mice and test the long-term therapeutic effects of this new technology.